Combining PrEP with contraception: a pilot test of an intervention to increase adherence to PrEP in adolescent girls and young women in Zimbabwe

HIV is the leading cause of death in adolescent girls and young women (AGYW) aged 15-24 years. Despite advances in
HIV treatment and prevention, AGYW remain at high risk, particularly in sub-Saharan Africa. Oral pre-exposure
prophylaxis (PrEP) is highly effective and has the potential to make a dramatic impact on the HIV epidemic. Yet to date,
most trials of PrEP in women have been unable to demonstrate efficacy, largely due to poor adherence among AGYW.
Emerging evidence indicates that women may be more likely to use an HIV prevention method that also prevents
pregnancy. We will test an intervention consisting of a single oral capsule providing both PrEP and contraception – a
contraceptive multipurpose prevention technology (cMPT) – as a strategy for increasing PrEP adherence compared to oral
PrEP alone. We will enroll AGYW who already use combined oral contraceptives (COCs) in Harare, Zimbabwe, where
AGYW continue to be at high risk of HIV, more than half of contracepting women use COCs, and less than 1% of 15-35-
year-old women are using PrEP. The cMPT intervention – a dual prevention pill (DPP) – will contain two marketed
products: Truvada® [emtricitabine and tenofovir disoproxil fumarate (TDF)] and a COC [levonorgestrel (LNG)/ethinyl
estradiol (EE)]. This research will implemented through a collaboration between the Population Council, which has global
expertise in clinical trial, implementation science, feasibility studies and evaluation around female-initiated HIV
prevention methods, and the University of Zimbabwe Clinical Trials Research Centre (UZ-CTRC), which has a long
history of conducting HIV clinical studies and prevention research. In Aim 1, we will conduct qualitative formative
research to explore the acceptability of combining Truvada with a COC to increase PrEP adherence through focus group
discussions with AGYW and in-depth interviews (IDIs) with healthcare providers. In Aim 2, we will incorporate
formative research findings into the development and pre-testing of 1) DPP packaging and client information materials; 2)
adherence and acceptability questionnaires; and 3) a provider training manual. In Aim 3, we will compare the
acceptability, preference, and adherence of the DPP intervention versus standard of care (2 separate pills: Truvada® and
COC). In a 6-month randomized, crossover study, 30 AGYW (16-24 years old) in Harare, Zimbabwe will be assigned in
random order to the sequence of the 2 regimens: the DPP or standard of care (2 separate pills). Each regimen will be used
for 3 28-day menstrual cycles (approximately 3 months per regimen). At the end of 6 months, women will be asked to
state their preference for the DPP or the 2 separate pills. We will assess and compare acceptability and adherence (via
dried blood spots) of the 2 regimens, and socioecological factors (e.g., individual-, partner-, family-, clinic-level)
associated with adherence and acceptability. We will explore facilitators and barriers to use through IDIs with 5 AGYW
who complete the study and all AGYW who withdraw early. Acquiring confirmation now on the preference for a DPP
from actual use with currently approved products will accelerate the availability of such a product in the marketplace.
Given supportive findings in this project, we will outline a process for regulatory approval of the more cost-effective co-
formulated pill.

Public health relevance
PROJECT NARRATIVE Results from several surveys show that the responding women support the concept of their contraceptive also providing pre-exposure prophylaxis (PrEP) for HIV. We plan to confirm these findings in an actual use study by combining an oral contraceptive and oral pre-exposure prophylaxis (PrEP) into a single gelatin capsule for use by adolescent girls and young women (AGYW) in Zimbabwe. The preference and tolerability findings from this study could support the concept of the fastest path to approval for a contraceptive pre-exposure prophylaxis (cMPT) product – a dual prevention pill (DPP) – co-formulating two marketed products into one convenient and discreet tablet, which should have an impact on reducing HIV incidence and unintended pregnancies in Zimbabwe and globally by increasing PrEP uptake and adherence among AGYW.